Mayo Clinic Nephrology & Urology Summer Undergraduate Research Fellowship (nuSURF)

Abstract: Mayo Clinic Nephrology & Urology Summer Undergraduate Research Fellowship (nuSURF)
The Mayo Clinic has a rich history in both basic science and clinic science research in Nephrology &
Urology, and has active PhD, MD and MD-PhD training programs. Annually, the Mayo Graduate School
receives >1200 applications from Undergraduates to work with Mayo Clinic Investigators. The Mayo Clinic is
home to both an O’Brien Urology Research Center as well as a Mayo Translational Polycystic Kidney Disease
(PKD) Center. Both Mayo Centers are one of four NIH funded Centers in the US. For the past several years,
both Centers have received supplemental funds to support summer undergraduate research related to kidney
stones and PKD, respectively. This proposal (renewal), in response to RFA-DK-18-006 (R25) merges these
three successful summer undergraduate programs (~115 students) into a more generalized Mayo Clinic
Nephrology & Urology Summer Undergraduate Research Fellowship (nuSURF). Several students from Mayo’s
programs have entered PhD, MD, or MD-PhD programs, or have co-authored Nephrology or Urology-oriented
peer-reviewed papers.
Over the next 5 years, we proposed to fund 14 students/summer (70 students total) through nuSURF to
work specifically with Mayo Investigators engaged in basic or translational research in Nephrology & Urology.
This 5 year period will allow undergraduates in the program to perform innovative Nephrology & Urology
research with leading Mayo Clinic research laboratories. Students will also participate in various educational
programs (e.g., weekly seminars and mini-courses) to enhance their research experience. Their 10-week
summer experience will culminate with (1) a 10-minute oral presentation of their work, (2) a Mayo-wide
Summer Undergraduate poster presentation (> 120 student/yr) and (3) a NIDDK-KUH Summer Undergraduate
Research Symposium held annually at the end of the Summer at one of the funded R25-centers. Following the
Summer Program, students will be academically tracked to determine the effectiveness of the Mayo nuSURF
experience in Nephrology & Urology, basic research and clinical medicine. Our goal is to increase the number
of basic and clinical Nephrology & Urology researchers as a result of this nuSURF training experience.

Public health relevance
Lay Summary The current proposal seeks to fund 14 undergraduate students annually to work with Mayo Clinic researchers in Nephrology or Urology. This 10-week summer program will pair undergraduates with Mayo Clinic researchers to carry out specific research projects. Additionally, students will participate in a research training course, take a cell and renal mini-course, organize their lab data into abstracts, oral research presentations and poster presentations. Talks will be given to Mayo faculty and posters will be presented at the NIDDK-KUH Summer Research Symposium held annually at the end of the Summer.